CORE--CELL CULTURE

The cell culture facility will function as a repository for the Case Western Reserve University colon cancer cell line bank and all newly derived cells from Project 1. It will provide individual projects with cell lines and ensure that the cell lines, the cell culture methods and cytotoxicity assays used in the Program are uniform. The centralization of this activity is an efficient and economic approach for providing the following specific technical and professional services. 1.Maintain a bank of human colon cancer cell lines and clones derived from these lines. 2.Provide quality control for the cell line bank by monitoring cell lines for alteration in drug sensitivity pattern; changes in growth characteristics and/or karyotype; and to monitor for cell-cell contamination and mycoplasma contamination. 3.Provide cell line models on demand to collaborating projects and assure the uniformity of the cell lines and culture conditions used in each project. 4.Develop specialized cytotoxicity assays for individual lines and assure that the cytotoxicity assays used by individual projects are uniform. 5.Maintain a repository for frozen clinical tissues.